OpenNeuro: An open archive for analysis and sharing of BRAIN Initiative data

Project Summary/Abstract The NIH BRAIN Initiative is supporting a broad portfolio of neuroscience research aimed at revolutionizing our understanding of the brain. The sharing of data obtained from this research is critical both to leveraging this major public investment and to ensuring the rigor and reproducibility of NIH-funded research. We propose to extend to the existing OpenNeuro data archive in order to provide a platform for the storage, processing, and sharing of neuroimaging data collected as part of the BRAIN Initiative. OpenNeuro extends the successful OpenfMRI project by encompassing a broader range of neuroimaging data, and by providing the ability to run data processing workflows on the data directly on the platform (using cloud computing resources) and share the results of those workflows alongside the data. The platform focuses on reproducibility through the use of versioned and containerized analysis workflows that are applied to snapshotted data releases. The proposed project would provide support for analysis and sharing of data from BRAIN Initiative projects as well as other interested projects. In addition to this infrastructure, the aims of the project are to develop a robust semi-automated curation workflow, implement new tools for federation, query, and identification, and develop support for advanced data processing workflows.

Public health relevance
Project Narrative The NIH BRAIN Initiative is developing research tools that will revolutionize the study of the brain, and one key to maximizing this investment is the open sharing of data collected as part of this research. We propose to implement a data archive for neuroimaging data collected as part of the BRAIN Initiative as well as by other researchers who wish to share data openly. The availability of these data will maximize the ability of researchers to understand the brain dysfunction associated with neurological and mental health disorders.